The long non-coding RNA LINC01133 as a novel determinant of immune evasion in triple-negative breast cancer

Triple-negative breast cancers (TNBCs) afflict younger women of African and Latino descent, present with
aggressive clinical behavior, and are in their majority unresponsive to systemic treatments. Patients with
refractory disease exhibit dismal survival rates with reliable therapies still undefined. To identify novel, disease-
relevant therapeutic targets, we conducted transcriptomic analyses of highly metastatic and tumor-initiating
TNBC cells, focusing specifically on long non-coding RNAs (lncRNAs), an emerging RNA family with
pleiotropic contributions to essential cellular processes. These efforts identified the lncRNA LINC01133, which
we found induced malignant tumor development by promoting the expansion of cancer stem cells (CSCs):
tumor-initiating cells at the origin of metastasis and therapy resistance. Importantly, LINC01133 associated
tightly with clinical TNBC and prognosticated poor patient survival. Further, LINC01133 expression, on its own,
promoted cancer growth in vitro and tumorigenesis in vivo. Importantly, LINC01133 inhibition by anti-sense
oligonucleotides (ASO) inhibited cancer cell growth, altogether ascribing LINC01133 critical role as a credible
therapeutic target in TNBC. Interestingly, LINC01133 exerted additional, paracrine activities that regulated how
TNBC cells interfaced with the tumor immune microenvironment (TIME). Indeed, LINC01133-generated
syngeneic murine mammary tumors exhibited evident immune-suppressed phenotypes with increased
myeloid-derived suppressor cells, M2 macrophages, and anergized 2B4+CD3+ T-cells, concomitant with
striking PD-L1 induction in LINC01133-cancer cells. These results allow us to hypothesize that LINC01133
regulated immune evasion, in addition to CSC genesis, representing an opportune and novel dual target in
immuno-oncology, and our objective is to verify these notions using three concerted aims. In Aim1, we will
determine how LINC01133 promotes the expression of the checkpoint protein PD-L1 by probing the molecular
events that foster PD-L1 accumulation (1.1), and by delineating the direct proximal molecular networks through
which LINC01133 regulates PD-L1 expression (1.2 and 1.3). In Aim2, we will comprehensively determine the
TIME constituents in LINC01133-expressing syngeneic immune-competent murine TNBC models using FACS
and immunohistochemistry (IHC) (2.1). Then, we will use ex vivo phenotypic and functional assays to
determine the extent to which tumor-purified infiltrating lymphocytes are exhausted/anergized in LINC01133-
expressing tumors (2.2) and determine LINC01133 impact on metastasis (2.3). To clinically validate these
findings, we will use quantitative PCR on cancer cells laser-captured from TNBC specimens to determine if
LINC0113 levels correlate with patient metastasis and survival history and/or IHC-determined T-cell-specific
exhaustion phenotypes in their tumors (2.4). In Aim 3, we will determine if LINC01133 inhibition stunts
tumor/metastasis growth by reawakening anti-tumor responses. For this purpose, we will use in vivo tumor-
targeted gene knockdown that uses Epcam RNA aptamers – structured RNAs that bind with high affinity to the
cell receptor Epcam, highly expressed in LINC01133-expressing CSCs – to deliver covalently linked small
interfering RNAs (siRNAs) against LINC01133 into TNBC growths in vivo. Knockdown occurs selectively in
Epcam-bearing cancer cells when aptamer-siRNA chimeras (AsiCs) are internalized/cleaved intracellularly to
liberate active LINC01133-siRNAs. Here, we will determine if Epcam-AsiC-LINC01133 causes immune-
mediated cancer regression in syngeneic and genetically engineered mouse models (GEMM) by conducting
comparative tumor growth kinetics, assessing cancer cell death/survival in treated tumors and metastases, and
by characterizing the phenotype and functionality of tumor-infiltrating lymphocytes ex vivo (3.1). Finally, we will
determine if AsiCs cooperate with immune checkpoint inhibitors in enhancing TIL-mediated cancer cell
clearance (3.2). Our studies will thus introduce novel inhibitors directed against two major determinants of
TNBC malignancy, CSC formation and immune escape, revolutionizing TNBC clinical management.

Public health relevance
Triple-negative breast cancer (TNBC) is a highly malignant breast cancer type that afflicts women veterans and possesses no effective or targeted therapies. Better understanding of how TNBC develops and progresses will lead to cures that save veteran lives. Using a recently developed TNBC model, we identified a novel molecular pathway that regulates the generation, propagation, and maintenance of so-called `cancer stem cells' (CSCs), the most malignant cells in the tumor and those responsible for recurrence, spread, and therapy resistance. We found that these CSCs are addicted to a molecule called LINC01133, a member of the long non-coding RNA family, and that LINC01133 promoted the formation of an immune-suppressed tumor microenvironment consistent with it fostering immune evasion. Here, we will elucidate LINC01133 immune pro-malignant functions and determine its utility as a therapeutic target in preclinical models, thereby introducing novel RNA immunotherapeutics of potential groundbreaking impact in managing aggressive and difficult-to-treat TNBCs.